REACTION AND ADJUSTMENTS OF PARENTS AND SIBLINGS OF THE PREMATURE INFANT

The purpose of this study is to identify the psychological adjustment of parents and siblings in families with infants in the Neonatal Intensive Care Unit and examine the coping strategies utilized to manage this stressful experience. The birth of medically ill and preterm infants can be a particularly stressful experience for parents and siblings. With advances in medical technology and increased survival rates of pre-term infants, many parents experience lengthy and stressful Neonatal Intensive Care Unit hospitalization of their infants. This results in adjustment difficulties, which impact both families and medical staff. Although there have been numerous studies focusing on the reactions of mothers with preterm infants, very few recent studies have addressed the reaction of fathers and siblings. One of the effects of the lack of substantial research in this area is that clinicians do not have adequate information on how to address these issues and provide treatment interventions. In this study, we propose to examine the prevalence and nature of adjustment difficulties in family members, and also examine coping strategies which are associated with improved outcome. Subjects recruited to the study will complete a number of self-report questionnaires that inquire about levels of stress, coping, and psychological adjustment in both parents and siblings. It is hoped that the result of this study will lead to possible treatment interventions to improve the experience of families with medically ill or preterm infants.